The fungiform papilla as a multi-sensory end-organ

Project Summary/Parent grant. Our perception of food in the mouth is a multi-modal sensory experience
involving taste, olfaction, and somatosensation. All of these stimuli combine to contribute to the recognition and
palatability of food. The first step leading to the perception of ‘mouth feel” in the oral cavity is activation of
peripheral somatosensory neurons. Multiple classes of these trigeminal somatosensory neurons innervate the
oral cavity and can be defined by the types of stimuli to which they respond. For example, low threshold
mechanoreceptors (LTMRs) carry information concerning touch or mechanical stimuli. In skin, at least 7 clear
subtypes of these neurons have been defined by using gene expression to relate the anatomical features of
these neurons with their functions. We do not know how many specialized neuron subtypes mediate touch
sensation in the tongue or their specialized anatomical and functional properties. Understanding the sensations
evoked by a food stimulus requires us to determine the unique anatomical and functional properties of each
LTMR subtype in the tongue. Equally important is how each LTMR’s activities are integrated with other oral
sensory neuron types (i.e. taste and temperature). Toward these long-term goals we propose to use two
genetic identifiers to examine trigeminal neuron subtypes innervating the fungiform (taste) papillae. Our Aims
specifically test the following hypotheses: 1) Taste papillae are innervated by a Aβ LTMRs with a small
receptive field that express the neurotrophin receptor, TrkC, and that they neurons can further be divided into
rapidly adapting and slowly-adapting types based on the presence or absence of Parvalbumin. 2) These Aβ
LTMRs project to the to a region of the brainstem immediately adjacent to the primary taste terminal field
where they activate postsynaptic neurons that are responsive to touch. 3) These Aβ LTMRs are capable of
modulating responses to taste stimuli at the first gustatory synaptic relay. Successful completion of these
experiments establishes the fungiform papilla as a mechanosensory end organ and provides the genetic tools
to explore the contribution of a specific subtype of LTMR in the integration of sensations produced by the multi-
modal food stimulus.

Public health relevance
Somatosensory neurons innervating the tongue contribute to numerous perceptual qualities, including texture of food and location of gustatory stimuli. Understanding their role in normal function is the first step in determining how they might be repaired when disrupted (peripheral neuropathies and/or burning mouth syndrome).